Microscopy and Histopathology Core B

Project Summary
The mission of the Microscopy and Histopathology Core B is to provide HDDC members with basic and
advanced microscope equipment, services and training, image processing resources, histology and
histopathology support, and support for experimental design and scientific analysis that are essential for
research in the digestive diseases.
Core B, which is a long-standing component of the HDDC, is a successful collaboration among three
independent imaging-based cores with their own financial structure that are each led by a director. The
three sites are Beth Israel Deaconess Medical Center (Site A), Boston Children’s Hospital (Site B), and
Brigham and Women’s Hospital (Site C). The three core sites are physically close to one another and
unified by a Core Director who oversees the relationship of each satellite core with the HDDC and its
membership. This infrastructure greatly benefits the HDDC membership by providing imaging equipment
and expertise in locations highly populated with HDDC users while also providing options to amplify
investigator-initiated research programs and enable new experimental approaches. This infrastructure
also allows for the successful integration of other Harvard-based core facilities specializing in advanced
instrumentation.
Nine services were offered for Core B in the past 5-year grant cycle with 39 HDDC Principal Members
and 13 Affiliate Members using Core B. Overall Core B recorded on average 4,200 billable service
hours/year and 16,858 total billable hours over the last 4 year grant cycle (2015-2019) with 95 (primary
use), 42 (secondary use), and 1 (tertiary use) original papers emerging from Core B utilization. HDDC
support significantly extended grant dollars by reducing the cost of services by 25% or more for HDDC
members. New innovations and equipment updates in the past grant cycle benefited, in particular, the
electron microscopy and confocal microscopy services and their users.
In the next grant cycle, the same nine services will be offered in Core B with 64 members indicating an
interest in using Core B services. In the advanced microscopy category, one new service in high
resolution 3-D electron microscopy will be available to HDDC members. Discounted services for HDDC
Principal Members will continue to extend grant dollars and priority access for all HDDC members should
facilitate greater productivity with cutting-edge instrumentation and expertise in the next grant cycle.

Public health relevance
Project Narrative Core B has proven to be and remains an essential and highly utilized component of the Harvard Digestive Diseases Center that significantly benefits its members. Core B is additionally relevant because it supports biomedical research that is funded by the NIH and has already been judged as important to understanding the pathogenesis or treatment of human diseases of the GI tract and liver.